DEVELOPMENT OF DE NOVO SEQUENCING ALGORITHMS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We are working with Marshall Bern to optimize his search algorithms. He is writing de novo software to be used on toxin and HIV samples.